FGFR1 Signaling in AgRP Neurons for Regulating Metabolism

PROJECT ABSTRACT
The long-term objective of this proposal is to determine the physiological role of hypothalamic FGFR1 in
metabolic regulation, establish a previously uncovered signaling pathway of FGFR1-PI3K-FOXO1 in AgRP
neurons that contributes to neuronal activity associated with obesity and its related diseases. We have previously
reported that α-klotho, a known anti-aging protein, is a novel humoral factor that targets hypothalamic AgRP
neurons, which regulate energy and blood glucose metabolism. Furthermore, inhibition of FGFR1 abolished the
downstream signaling of α-klotho, negated its ability to modulate AgRP neuron activity, and blunted its
therapeutic effects, suggesting an important central FGFR1 mediated signaling. However, conventional selective
genetic deletion of FGFR1 in AgRP neurons has previously failed to produce a notable metabolic phenotype,
which may be due to potential compensatory effects induced by the absence of FGFR1 during development.
Based on this discrepancy, the overall goal of this project is to determine whether FGFR1 signaling in mature
AgRP neurons is required for the homeostatic regulation of energy balance. The proposed studies will utilize
selectively targeted loss- and gain-of-function approaches (AAV/CRISPR/CAS9) and mouse models of obesity
and diabetes to identify the neuronal and molecular mechanisms underlying FGFR1 metabolic effects.

Public health relevance
PROJECT NARRATIVE Obesity is the primary risk factor for the development of type 2 diabetes and other diseases such as hypertension and cardiovascular disease. It is often associated with an energy imbalance that contributes to dysregulation of body-weight homeostasis. Findings from proposed studies will establish the novel role of AgRP neuron FGFR1 signaling in energy regulation that will have the potential to significantly advance our knowledge in the field of metabolic physiology.